Preclinical assessment of efficacy and tumor microenvironment alterations by PPRX-1701 in glioblastoma

Project Summary/Abstract
The malignant brain tumor glioblastoma (GBM) remains incurable with little improvement in patient outcomes
over many decades. The success of immunotherapies such as immune checkpoint blockade (ICB) in other
cancers has not been replicated so far in GBM. Effective application of immunotherapy for GBM may need
combination therapies based on detailed understanding of molecular biology and immunosuppressive
mechanisms in the tumor microenvironment (TME), as well as preclinical studies of rational synergistic
therapeutic combinations to inform and develop effective future clinical trials. In this resubmitted R21 proposal
we will build on preliminary data showing inhibition of expression of IDO1 and altered TME in GBM by the drug
PPRX-1701, a newly developed bioavailable formulation of the indirubin derivative 6-bromoindirubin-3'-
acetoxime (BiA), to understand its mechanism of action and provide preclinical data which may support its use
in human GBM patients. BiA is a chemically modified form of indirubin, a natural product derived from the indigo
plant which is an active component of anti-inflammatory Traditional Chinese Medicines, which has been used to
treat chronic myelogenous leukemia and psoriasis. Our previously published studies showed that BiA could
prolong survival of human GBM xenografts in mice via effects on invasion, proliferation and angiogenesis.
However, we did not examine the potential immunological effects of BiA, and the further development of this
concept was hampered by poor solubility which limits applicability in patients.
PPRX-1701 is a BiA/copolymer nanoparticle suspension that can be efficiently systemically delivered safely by
intravenous injection, where it increases survival in GBM-bearing immunocompetent mice. Our initial studies of
PPRX-1701 in murine GBM show targeting of intracranial tumors and alterations in TME composition including
increased CD8+ T cells, and decreased tumor promoting macrophages. We have also shown that BiA/PPRX-
1701 potently blocks induction of the immunosuppressive enzyme IDO1 by interferon- We therefore
hypothesize that BiA/PPRX-1701 promotes alterations in the TME as a result of inhibition of immunosuppressive
pathways, increasing animal survival and anti-tumor immunity. Here we propose in Aim 1 to determine optimal
dosing, biodistribution, toxicity and efficacy in multiple murine GBM models. In Aim 2 we will characterize in
detail the molecular and cellular alterations associated with PPRX-1701 treatment in vivo, and test combination
immunotherapies with a view to clinical translation if data supports.
The experiments described here will rapidly establish mechanism and applicability of PPRX-1701 for GBM
treatment, and provide a platform for future detailed studies and informed clinical trials.

Public health relevance
Project Narrative Modulation of the cellular composition of immunologically cold tumors such as glioblastoma (GBM) may be a useful approach for combination treatments alongside systemic immunotherapies. We have identified that delivery of chemically-modified derivatives of the Chinese traditional medicine component indirubin via a novel nanoparticle formulation promotes survival of GBM-bearing mice and alters tumor cellular composition. Here we will perform mechanistic and survival studies in mouse GBM models to provide support for new therapeutic approaches in GBM patients.